STAT3 inhibition as a therapeutic strategy against MDS stem cells

Myelodysplastic syndromes (MDS) are generally incurable hematologic disorders associated
with disease initiating stem cells that are not eliminated by conventional therapies and need to
be targeted for potentially curative strategies. We recently demonstrated that aberrant
hematopoietic stem cells are expanded in MDS, can persist during phenotypic remissions and
can predict relapse. STAT3 is a transcription factor that was found to be overexpressed in MDS
stem cells and higher expression was associated with an adverse prognosis in a large cohort of
patients. We also obtained proof-of-concept data that inhibition of STAT3 can target malignant
stem cells while sparing healthy control stem and progenitors, thus identifying it as a potential
therapeutic target in MDS. To comprehensively examine the role of this pathway in MDS, Aim 1
will define the functional role of STAT3 on growth of disease initiating stem cells in MDS and
determine the efficacy of clinically relevant inhibitors of this pathway in large cohort of primary
human samples. Additionally, in vitro and in vivo efficacy of a clinically applicable, anti-sense
inhibitor (AZD-9150) against a large number of primary MDS samples will be correlated with
clinical and mutational subtypes to identify subsets that will be sensitive to STAT3 inhibition.
Patient derived MDS xenografts will also be used to determine in vivo efficacy. Aim 2 will
determine the requirement for STAT3 in initiation of dysplasia/disease progression in vivo by
genetic deletion of STAT3 in two mouse models of MDS. Along with the NUP-HOXD13 model; a
novel model of MDS dysplasia and transformation which we have recently developed, induced
by heterozygous PU.1 enhancer deletion, will be used to study the effect of STAT3 deletion on
disease initiating stem cells and disease progression. Aim 3 will identify the downstream
effectors of STAT3 activation in MDS. Combination of Chip-seq and transcriptomic profiling will
be used to identify direct targets of STAT3 activation, that will tested in functional assays in
MDS models. We will also determine the role of MCL-1 as a downstream anti-apoptotic target of
STAT3 activation in MDS stem cells. Identification of critical downstream effectors will improve
our molecular understanding of the STAT3 pathway in MDS and will be instrumental to develop
more specific and potent strategies to inhibit this pathway. Taken together, these studies will
study the role of the STAT3 pathway in MDS pathogenesis and determine its potential as a
therapeutic target against immature, disease initiating cells in MDS.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Myelodysplastic syndromes (MDS) are common blood cancers that are characterized by high rates of disease relapse. Disease causing stem cells are not eliminated by conventional chemotherapies and need to be targeted to prevent relapse and achieve long lasting remissions. Preliminary data show that the levels of activated STAT3 are very high in MDS stem and progenitor cells, are predictive of worse outcomes in patients, and can be used to target disease causing cells. In the proposed studies, we will determine the intracellular pathways activated by STAT3 in MDS cells, and test the efficacy of novel STAT3 inhibitors in MDS.